Expanding access to colorectal cancer screening through community pharmacies: The PharmFIT study

Project Abstract (Summary)
Medically underserved populations are disproportionately affected by screen-preventable cancers, such as
colorectal cancer (CRC). Entities such as the United States Preventive Services Task Force and the American
Cancer Society recommend fecal immunochemical testing (FIT) as an effective home-based method for CRC
screening. Annual FIT, when followed by a diagnostic colonoscopy for a positive result, can reduce CRC
mortality on a population level. CRC screening is traditionally delivered as part of a medical visit. However, due
to short visit times and competing demands among providers and patients alike, patients, even those who
regularly attend medical visits, may miss out on screening, putting them at a higher risk of serious disease.
FITs can be easily distributed in non-traditional healthcare settings and can help bridge the gap in care for
underserved populations. Community pharmacies hold promise as a site for CRC screening because of their
accessibility and pharmacists’ expanding role in delivering preventive services. Based on our formative and
pilot work demonstrating the acceptability, feasibility, and preliminary effectiveness of FIT delivery in
pharmacies, our objective is to evaluate the effectiveness and implementation of a pharmacy-based FIT
intervention called PharmFIT. Through collaboration with community partners such as the North Carolina
Network Consortium (NCNC), the Washington, Wyoming, Alaska, Montana, and Idaho Practice Research
Network (WPRN) and the Community Pharmacy Enhanced Services Network (CPESN), our aims are to: 1)
evaluate the impact, 2) assess the implementation, and 3) estimate the costs of the PharmFIT intervention. We
will conduct a randomized controlled trial to assess the impact of PharmFIT on CRC screening rates in eligible
primary care patients who are not up to date. Patients will be individually randomized to a usual care arm or a
PharmFIT arm and we will determine whether there are statistically significant differences in CRC screening
rates. Concurrently, we will use a mixed-method approach to assess a range of preliminary implementation
outcomes and identify barriers and facilitators (i.e., determinants) of those implementation outcomes. Finally,
we will calculate the cost of PharmFIT using collaborative process flow diagramming to inform micro-costing
and budget impact analysis. We hypothesize that the PharmFIT intervention will increase CRC screening
uptake over usual care by providing better access and more opportunities for preventive services through a
collaborative pharmacy/primary care approach.

Public health relevance
Project Narrative The proposed study is relevant to public health because expanding access to colorectal cancer screening through pharmacies located in medically underserved communities will improve prevention and early detection of cancer. Supported by preliminary work demonstrating the acceptability, feasibility, and estimated effect of the PharmFIT intervention, this is the first trial to systematically evaluate pharmacy-based CRC screening using FITs in the US. Findings related to the impact, implementation, and cost of PharmFIT will generate new knowledge about interventions delivered by community pharmacists and contribute to NCI’s mission to fund research that will reduce cancer disparities.